Pre-Clinical 7T MRI for Oklahoma

Project Summary We are proposing to update our current Bruker Biospin Advance I 70/30 USR pre-clinical MR imaging system (originally set up in 2004) to an Avance III HD (AV3) console upgrade with Paravision 6 software, not including the 7T (Tesla) 30 cm magnet, gradient and shim coils, gradient/shim cooling, RF amplifiers, shim amplifier, and Farady cage. For the proposed application, the major projects consist of 5 funded NIH R01 projects (Towner, Sun, Ahamed, Wu, and Deshmukh), a pending NIH R01 application (Srinivasan), a funded NIH R21 project (Plafker), and a funded American Cancer Association project (Woo), as well as 4 minor projects (Towner, Deak, Chen), primarily from two institutions (Oklahoma Medical Research Foundation (OMRF) and the University of Oklahoma Health Sciences Center ( OUHSC)), that will all directly benefit from the AV3 and Paravision 6 equipment upgrade. The proposed Advance III HD hardware and Paravision 6 upgrades to the 70/30 USR Bruker Biospin small animal MRI system will allow researchers in Oklahoma, particularly OMRF and OUHSC, to obtain faster, non-distorted imaging data for neurological, cardiac and tumor investigations. The projects range in biomedical research from neurological diseases (Towner (OMRF) – septic encephalopathy; Plafker (OMRF) – optic neuritis; Deak (OUHSC) – Alzheimer's disease), cardiac diseases (Sun (OUHSC) – cardiomyopathy; Ahamed (OMRF) – cardiac fibrosis), cancer (Wu (OUHSC) – lung cancer; Ramesh (OUHSC) – nanoparticle-based gene delivery for cancer treatments; Woo (OUHSC) – anti-angiogenic therapy for ovarian cancer; Chen (UCO) – metastatic tumor therapy using combined laser and immunoadjuvant therapy), autoimmune diseases (Plafker (OMRF) – autoimmune demyelinating optic neuritis; Deshmukh (OMRF) – Sjogren's syndrome); vascular-related diseases (Srinivasan (OMRF) – lymphatic system formation and lymphedema); to obesity (Towner – molecular alterations).

Public health relevance
Project Narrative We are proposing to update our current pre-clinical MR imaging system with more modern hardware and software that will allow our MRI Facility to obtain faster, non-distorted imaging data for neurological, cardiac and tumor investigations, primarily at two biomedical research institutions in Oklahoma. The projects consist of five NIH-R01 grant-funded research studies that range in biomedical research from neurological diseases – septic encephalopathy, optic neuritis, and Alzheimer's disease; cardiac diseases – cardiomyopathy, and cardiac fibrosis; cancer – lung cancer, anti-angiogenic therapy for ovarian cancer, and metastatic tumor therapy using combined laser and immunoadjuvant therapy; autoimmune diseases – autoimmune demyelinating optic neuritis, and Sjogren's syndrome; vascular-related diseases – lymphatic system formation and lymphedema; to obesity – molecular alterations.